Flow Cytometry Module

Flow Cytometry Module
Abstract
The objective of the Flow Cytometry Module is to enhance the capabilities of individual investigators to conduct
cutting edge research in the vision sciences. Our Aims are: 1) to provide resources, support and training
required to utilize flow cytometry for phenotypic and functional analyses of cells from ocular tissues at the level
exceeding the capabilities of any individual laboratory; 2) to promote collegiality across the community of vision
scientists through sharing resources, techniques and expertise; and 3) to engage colleagues into conducting
vision research, including support of the next generation of basic and clinician scientists. These Aims will be
achieved through support of a sophisticated facility equipped with state-of-the-art flow cytometers and data
analysis software. This facility is supervised and operated by highly experienced specialists, who provide
expertise and support in cell preparation, data acquisition, analysis and interpretation. These shared resources
will support ongoing projects and open new research possibilities for both experienced and novice users, and
will serve as a platform for fostering interactions among a broad swath of our research community.